Monitoring and increasing resilience of stem cell derived pancreatic islet cell grafts

Project Summary/Abstract
Therapeutic options for people living with type 1 diabetes (T1D) are limited to lifelong management of glucose
levels with exogenous insulin. Recently, Teplizumab, a CD3 antibody received FDA approval which can delay
or halt progression of T1D and may be a cure for some patients. The only other therapeutic option is the
transplantation of donor derived pancreatic islets, resulting in a functional cure by negating or easing the life-
long need for onerous management with insulin. In addition to being a constant burden on people’s life,
exogenous administration of Insulin cannot normalize glucose metabolism due to considerable delayed
pharmacokinetics. ß-cell replacement therapy is currently limited by the supply of primary islets as well as a
gridlock with the FDA which failed to approve islet transplantation in the US. A recent clinical trial with stem cell
derived islets has proven the concept of replacing ß-cells with this unlimited cell source. But major limitations
remain, such as the need for immunosuppression which has an unfavorable risk-benefit ratio in most people
with Type 1 Diabetes. Allogeneic islet cell grafts face multiple hurdles in the transplant recipient : The first is
engraftment in the transplant site which can involve direct exposure to Blood (intraportal infusion) or tissue that
has experienced surgical trauma. The subcutaneous and intramuscular transplant sites that we are developing
represent an inflammatory environment undergoing tissue repair, which can cause inflammatory stress and
death of implanted cells. Second, and most significant hurdle is allogeneic rejection by the host’s immune
system. In people with T1D, the potential autoimmune recognition of allogeneic beta cells is another challenge.
We have discovered a mechanism that renders beta cells resistant to inflammatory stress induced by cytokines
and preventing the loss of beta cells in murine models of autoimmune T1D. This mechanism is mediated by
deficiency in the TET2 gene, coding for an enzyme that effects epigenetic modifications. Here we propose to
harness that mechanism to develop a sc-Islet product that may overcome the hurdles of non-specific
inflammation and targeted immune response in the host. Here we propose to assess the effect of TET2 KO in
sc-Islets on cytokine induced inflammatory stress as well as on the allogeneic and antigen-specific,
autoimmune cellular immune response. A second product development we are proposing is to leverage our
proprietary nanosensor technology to measure the intracellular response to inflammation to enable non-
invasive monitoring of the sc-islet graft. There is currently no other method available to detect inflammation in
live cells. Our nanosensors detect microRNAs specific to cell states such as inflammation (miR146a) and emit
a signal we detect by Raman spectroscopy. These two technologies converge to a product that is more
resilient to inflammation and allows detection of a compromised graft prior to more definite readouts such as
declining or lost graft function, opening a window for therapeutic intervention such as local or systemic anti-
inflammatory or immunosuppressive treatment to prevent graft loss.

Public health relevance
Project Narrative The success of beta cell replacement therapy for patients with type 1 diabetes (T1D) suffers from a paucity of donor islets, an inhospitable transplant environment that causes graft failure, and the absence of sensing technology capable of monitoring cell health, function, and duress. We address these challenges by generating surrogate islet organoids from stem cells and engineering them to resist inflammatory strense and immune rejection as well as to sense molecular biomarkers for cellular dysfunction. Our proposal describes novel strategies for an inflammatory stress resilient ß-cell replacement product that can be monitored non-invasively for cellular health with direct implications for long-term survival and function of sc-islet grafts, leading to insulin independence for patients with T1D.